Programs for the Training and Advancement of the Next GENeration of Native Researchers in Genetics, Ethics and Society

The lack of American Indian and Alaska Native professionals in genomic sciences today highlights
the tremendous need for effective training and research programs to prepare the next generation of
Native students to be successful in their pursuit of careers in genetics research. Early and
meaningful exposure to degree programs and research experiences are critical for the inclusion and
advancement of Native students in establishing pathways toward careers in genomics. The proposed
Genetics and Ethics in Native Communities (GEN) Program is a five-year research and training
program for undergraduate and graduate Native students interested in pursuing questions related to
genetics, health and society. Our proposed program combines didactic and experiential training
activities, together with Indigenous and community-based models of learning, as a means for Native
students to directly shape the field of genomics in ways that promote the values and perspectives
of Indigenous experiences. The four main components of the GEN program include 1.) an online course
on genomics and ethics in Native communities; 2.) a paid fellowship program for Native students to
connect with ongoing training opportunities and research experiences both on site and within a
larger network of supporting institutions; 3.) a summer intensive field-based research methods
course for individual student project development; and 4.) a biennial student research conference
designed to showcase the next generation of student achievements in genomics research.

Central to our proposed program is the Genomics and Ethics Program for Native Students (GEN), a
fellowship program designed to foster collaborative learning communities for the advancement of
Native students in the ethical, social and legal implications of genetics and society. The
fellowship is founded upon a community of learners approach that works toward the creation of
sustainable, supportive learning environments for Native students by grounding all training
activities in indigenous knowledge and methodologies, intergenerational learning, professional
indigenous networks, and the value of social cohesion (Ball, 2004). A priority for this fellowship,
and the entire program as a whole, is to provide Native students with opportunities to participate
in community-based training and research activities that are grounded in indigenous experiences,
which is why every activity offered as part of the GEN program is a collaborative effort between
personnel at the Center on American Indian and Alaska Native Genomic Research (CAIANGR) and a
network of Indigenous professionals, Native-serving programs, tribal leaders and community members,
and fellow cohort members. A primary outcome of the proposed activities is the recruitment and
retention of Native student researchers in the field of genomics and society, but we expect that
this training program can also serve as a model for inserting Indigenous perspectives at the
forefront of the growing science of genomics.

Public health relevance
Project Narrative The lack of American Indian and Alaska Native professionals in genomic sciences today highlights the tremendous need for effective training and research programs to prepare the next generation of indigenous students to be successful in their pursuit of careers in genetics research. This program combines didactic and experiential training activities, together with indigenous and community-based models of learning, to engage underrepresented Native students in research on the ethical, legal, and social implications of genomics research. This program is designed to promote an inclusive and supportive environment for American Indian and Alaska Native students to shape the field of genomics in ways that promote the values and perspectives of indigenous experiences.